HPV and host factors in juvenile onset recurrent respiratory papillomatosis

ABSTRACT. Patients with juvenile-onset recurrent respiratory papillomatosis (JoRRP) suffer from recurring
epithelial papillomas along the respiratory tract caused by low-risk H PV viruses, predominantly H PV6. This most
common benign neoplasm in children varies significantly in clinical course. Patients undergo an average of 4-5
surgeries in the first year post-diagnosis, and severe cases can result in hundreds of surgeries and progression
to cancer. The lack of effective medications significantly lowers the quality of life for children with RRP, and
highlights the need for new biomarkers and therapies. To develop therapeutics and prognostic markers requires
overcoming a deep gap in knowledge of viral and host cell factors that produce papillomas (ie, candidate targets
and markers). This is now possible thanks to the development of models of normal and JoRRP 3D stratified
squamous epithelium (SE). Using fresh tumor and matched nondiseased (ND) tissue from children with JoRRP,
we generated primary monolayer keratinocytes, which we then engineered into organotypic epithelial rafts. With
this established pipeline of internally controlled 2D/3D models, we have made significant strides.
Our global transcriptome analyses of 2D JoRRP/ND keratinocytes defined a JoRRP-specific EMT-like
disease signature, which we validated in rafts and patient specimens. Single-cell RNA sequencing (scRNAseq)
of HPV6+ RRP specimens (vs matched HPV- ND controls) further uncovered 16 transcriptionally distinct
keratinocyte subpopulations (clusters C0-15). CS bears striking similarity to our recently published cancerassociated
"HI ODEN" subpopulation induced by high-risk HPV16. Both are located in superficial layers where
H PV amplification occurs, and both share biomarkers including the ELF3 transcription factor, which is required
for HIDDEN formation.
Our new data show that the HPV16 E6/E7 oncogenes are sufficient to induce HI ODEN, suggesting that
conserved HPV6 E6/E7 activities might induce analogous subpopulations at the epithelial surface. In Aim1, we
test whether and how HPV6 E6 and/or E? induce CS, and whether CS is required for viral progeny production.
Our scRNAseq data also revealed striking abundance of HPV6 E5γ and δ transcripts across clusters, indicating
importance for viral processes and/or keratinocyte phenotypes. While functions of low-risk HPV E5γ/δ proteins
are unstudied in translational disease models, HPV6 E5γ was reported to bind the EGFR and ERBB2 receptor
tyrosine kinases. In Aim2, we test whether HPV6 E5γ and/or E5δ sustain JoRRP phenotypes, and whether they
do so, at least in part, via EGFR/ERBB2 signaling.

Public health relevance
NARRATIVE. Juvenile-onset recurrent respiratory papillomatosis (JoRRP), caused by human papillomaviruses, are benign airway tumors whose repeated growth requires young patients to undergo frequent surgeries and can lead to malignancy and death. Using surgical specimens from dozens of JoRRP donors, we recently established rigorous laboratory models that, for the first time, allow for the studies required to develop much needed cures/drug treatments and also predictive biomarkers. With these break-though models, we propose to build on our substantial preliminary data to determine how viral and cellular factors coordinate to promote RRP disease, and to use the resulting data to explore diagnostic tools and therapeutic targets.